RCMI Investigator Development Core

SUMMARY / ABSTRACT - INVESTIGATOR DEVELOPMENT CORE
The RCMI Cancer and Health Disparities Research Center at Xavier University will continue the development of
an Investigator Development Core (IDC) that will focus on enhancing the biomedical and health disparities
research capacity of early-stage faculty. The IDC will achieve this goal by providing a pilot project program to
develop preliminary data or analyze existing data, along with multiple early career/research development
activities through a Research Development Network that will include matching of investigators with
collaborators and mentors and the introduction to multiple research resources. These activities will start as soon
as new faculty are hired, will continue during pilot project research, and remain as investigators move forward to
become research competitive. To accomplish these goals, the IDC will achieve the following two specific aims:
Specific Aim 1: To establish a pilot project program focused on early career investigators working in
collaboration with an established mentor and/or collaborator to develop research capacity and
competitiveness by generating preliminary data or analyzing existing data for submission of external
grant applications. The goal of this program is to support early-stage investigators to develop research projects
addressing diseases that disproportionately impact minorities or other disparity populations, or that otherwise
address health disparities. These pilot projects will be awarded on a competitive basis, may be funded for up to
two years of support and will generate preliminary data for the submission of peer reviewed publications and
external grant applications. The involvement of minority faculty will be emphasized and encouraged. This
program will require mentors/collaborators to be active participants in the pilot research process as well
as resulting publications and grant applications. The accomplishment of this aim will result in more early-stage
faculty at Xavier obtaining high quality preliminary data or performing significant analysis of existing data and
publications that will be incorporated into an increased number of competitive external grant applications being
submitted. Specific Aim 2. To coordinate and implement training and mentoring activities focused on
increasing the research competitiveness of early-stage investigators. The establishment of a Research
Development Network will link early-stage investigators to mentors and collaborators as well as the resources
of the Xavier RCMI program and other resources at Xavier and the region with the single goal of building strong
collaborative research projects that will be competitive for achieving external funding. A particular effort will be
made to develop minority faculty. Accomplishment of this aim will result in more early-stage investigators at
Xavier participating in mentored collaborations involving established researchers, more pilot applications, more
high-quality publications, more competitive applications for external grant funding and ultimately more research
awards, particularly those addressing health disparities issues.